New Methods for the Concise Synthesis of Bioactive Polycyclic Molecules

PROJECT SUMMARY/ABSTRACT The discovery and development of effective chemical therapeutics for human disease is limited by the shortcomings of synthetic chemistry that make investigating important chemical structures difficult. In particular, the clinical potential of many complex polycyclic structures is under-explored due to a lack of methods for their preparation. Bridging this gap will allow many new structures to be synthesized rapidly, leading to an increased rate at which new therapeutics are discovered. Our long-term goal is to make significant contributions to both chemistry and medicine by developing general synthetic methods to construct biologically active complex polycyclic structures. The overall objective of our current research is to develop the oxidative coupling of silicon-tethered enolates as a powerful method to prepare complex structures that contain contiguous stereocenters. The paucity of available methods limits the use of such structures in chemical library synthesis and makes the efficient preparation of clinically relevant natural products difficult. Our rationale for investigating silyl bis-enol ethers is that they can mediate the coupling of two different chemical fragments and simultaneously control the stereochemical outcome of bond formation, thereby affording concise syntheses of complex structures. The Specific Aims of this proposal are: 1. Develop and utilize silyl bis-enol ether-based oxidation as a powerful new method to construct contiguous stereocenters; 2. Develop multicomponent coupling processes for rapid generation of complex bioactive molecules; and 3. Develop new oxidative bond-forming reactions that extend beyond enol-enol coupling. This proposed research is innovative because the silicon-tether acts to control both heterocoupling vs. homocoupling, and stereoselectivity for oxidative enolate bond formation. The development of techniques for fashioning quaternary stereocenters, vicinal stereoarrays, and tandem multicomponent coupling sequences will generate complexity efficiently. Additional research into Lewis base activation will provide enantioselective methods for preparing these structures. The invention of new oxidative bond-forming reactions will expand the usefulness of the silicon-tether concept to a wealth of challenging compounds. The expected outcomes of this research will be the concise synthesis of many medicinally important structures that are of significant challenge to current methods. This proposed research is significant for human health because it is expected to provide complex polycyclic structures in quantities that will ensure their utilization in discovering new chemical therapeutics.

Public health relevance
PROJECT NARRATIVE This proposed research will generate new methods to prepare biologically important polycyclic molecules. The synthesis of these unexplored structures will have an important positive impact on human health by allowing in-depth biological studies, and thus unearth new drug candidates and biological targets for combating diseases such as cancer.